Mapping the structural basis for mechanistic diversity in metalloenzyme superfamilies

Project Summary
The parent grant for this supplement aims to discover novel enzymatic cofactors involved in DNA biosynthesis
in pathogens. The overarching goal is to enable new routes to enzyme inhibition in bacteria that cause infectious
disease. Here we will investigate the mechanism of assembly of an essential tyrosine-derived post-translationally
modified radical cofactor found in a subclass of microbial ribonucleotide reductases through incorporation of non-
native amino acids. This approach will allow us to identify aspects of cofactor assembly that could be targeted
for disruption by therapeutic interventions. In a second aim, we will characterize the cofactor used by this enzyme
subclass in a native host organism. The project as a whole will set the stage for understanding how this enzyme
subclass is used inside the cell, ultimately allow us to test the impact of disruption of cofactor assembly in a
relevant biological context. The project provides an excellent training opportunity for the Ph.D. candidate
supported by the supplement in work at the interface between chemistry and microbiology. A collaborative
mentoring team is in place with expertise in non-native amino acid methodology, structural and biochemical
characterization of proteins, and cultivation of pathogenic and commensal microbes.

Public health relevance
Project Narrative Radical enzymes perform challenging but essential transformations of nucleic acids in biological systems. We seek more detailed understanding of how a certain class of nucleic acid biosynthetic enzymes assemble their radical cofactors. These efforts will allow us to target these systems for inhibition in pathogens.